Investigating the role of CARM1-mediated methylation of Qki in glioblastoma

PROJECT SUMMARY
Glioblastoma (GBM), the most common and deadly form of primary brain tumor in adults, is defined by high
molecular heterogeneity that renders tumors highly refractory to therapy. Glioblastoma stem cells (GSCs) are a
key population within this heterogeneity, harboring proliferative and self-renewal capacities to promote growth,
invasion, and resistance. Deciphering key mechanisms of GSC maintenance during gliomagenesis will inform
the development of novel GBM therapeutic strategies. Our lab has characterized Quaking (Qki), which is lost in
50-60% of GBM cases, as an important GBM tumor suppressor. Deletion of Qki in a pre-malignant genetic mouse
model induces the formation of GBM tumors. Mechanistically, Qki functions as a transcriptional co-activator that
regulates both the protein and lipid compartments of the endolysosomal system. Notably, Qki loss compromises
endolysosomal degradation and enriches self-renewal receptors at the cell surface, enabling GSCs to maintain
stemness and expand outside their niche. It remains to be explored whether other mechanisms of Qki
dysregulation govern the maintenance of GSCs in cases where Qki remains intact. Cancer genomic data reveals
recurrent mutations to specific Qki arginine residues that implicate the dysregulation of arginine methylation,
which is catalyzed by protein arginine methyltransferases (PRMTs). Previous studies reveal that Qki interacts
with a PRMT called co-activator associated arginine methyltransferase 1 (CARM1), and our preliminary data
shows that Qki is selectively methylated by CARM1. In this proposal, I intend to elucidate the role of CARM1-
mediated methylation of Qki in the maintenance of GSCs during gliomagenesis. By establishing stable Qki
methylation mutant cell lines and generating a novel genetic mouse model with the brain-specific deletion of
CARM1 on a pre-malignant background, I will employ a range of molecular, cellular, bioinformatic, and lipidomic
experimental approaches with aims to 1) characterize the molecular function of CARM1-mediated methylation
of Qki and 2) determine the impact of Qki arginine methylation on endolysosomal degradation and
gliomagenesis. Successful completion of this proposal will provide critical insight into novel
pathomechanisms underlying GBM and illuminate new GBM therapeutic strategies that utilize Qki
methylation status as a determinant for patient stratification. Moreover, this proposal will provide me, the
Principal Investigator, with rigorous technical training and valuable experiences tailored for my development as
an innovative researcher. The lab of my sponsor Dr. Jian Hu at MD Anderson Cancer Center represents an
exceptional environment for me to complete my project. Additionally, my co-sponsor Dr. Mark Bedford provides
critical mentoring, scientific expertise, and technical support to enrich my project and education. With my
graduate program, I will receive extensive training in the foundations and applications of cancer biology and
varied opportunities to prepare me for my career goal of becoming an independent academic researcher.

Public health relevance
PROJECT NARRATIVE Glioblastoma (GBM), the most prevalent and lethal adult brain tumor, is driven by glioblastoma stem cells (GSCs), which are tumor-initiating cells that promote rapid proliferation, invasion, and therapeutic resistance. Utilizing comprehensive biochemical approaches and a novel genetic mouse model, this research seeks to uncover a novel axis whereby dysregulated arginine methylation of Quaking (Qki), an important GBM tumor suppressor, regulates the self-renewal capabilities of GSCs to promote gliomagenesis. The results of this project can be leveraged for the development of new GBM treatment paradigms by utilizing Qki methylation status for patient stratification.